Fostering Collaborative Parent-Child Physical Activity through a Novel AI-Powered App: A Feasibility Pilot

PROJECT SUMMARY/ABSTRACT
Despite recognition of the pressing issues of high rates of childhood obesity and insufficient moderate-
to vigorous-intensity physical activity (MVPA) across the lifespan, few effective programs exist to support
family-based behavior change for physical activity (PA) promotion and weight gain prevention. Family-based
PA promotion interventions may be well-suited to support PA improvements in parents and children in the pre-
adolescent period (i.e., 9-12 years old), as parents are still seen as an important role model to children during
this developmental stage, and intervention at this time could help prevent further declines in child PA seen
during adolescence. Novel methods to facilitate family engagement are needed to optimize MVPA outcomes.
One highly promising yet underexplored approach to facilitating family engagement in MVPA is to leverage
mobile technology in concert with collaboration for support and motivation. Thus, this proposal addresses a
novel goal: providing comprehensive support for collaborative MVPA—before, during, and after PA. Literature
suggests that collaboration can lead to improved PA outcomes by enhancing motivation and accountability,
though most studies to date have been conducted with adults, and none with families or children. Our team
recently built a prototype app that was piloted in two small studies demonstrating its early usability; the app
displays key data including HR zones for facilitating MVPA collaboration between parents and children.
The present application proposes to refine and investigate the benefits of the FamilyCollab system, to
demonstrate the ways in which it supports parent-child dyads in pre-MVPA goal setting, collaborative real-time
MVPA, and post-MVPA reflection. Using smartwatch data, personalized family goal setting, and interactive AI
chat, the FamilyCollab system will support collaborative MVPA and achievement of the MVPA
recommendations for parents and children. Then, the FamilyCollab app will be tested in a randomized
feasibility pilot, compared to the same smartwatch with its standard commercial app. The objective is to refine
the FamilyCollab app and gather data on the feasibility and acceptability of this approach in preparation for a
larger efficacy trial. SPECIFIC AIMS: Aim 1: Refine the FamilyCollab App. The team will refine the
FamilyCollab app through two rounds of usability studies with (n=12 dyads; parents with children 9-12 years
old). These studies will finalize layout and features, along with ensuring usability and acceptability, ahead of
Aim 2. Aim 2: Feasibility Pilot. A total of 60 parent-child dyads will be randomly assigned to the FamilyCollab
Condition (intervention) or the Comparison Condition (control), where dyads will use the same smartwatch and
its standard commercial app. The primary outcomes of the FamilyCollab intervention will be feasibility,
measured as rates of dyad recruitment and retention; acceptability of the approach; and engagement with the
FamilyCollab system after 12 weeks. Exploratory outcomes will include changes in MVPA, BMI, and family
functioning (i.e., communication, support, cohesion) at 12 weeks.

Public health relevance
PROJECT NARRATIVE There is an urgent need for innovative approaches to address the prevention of pediatric obesity and encourage physical activity in parents and children. One underexplored approach to facilitating family engagement in physical is leveraging collaboration for support and motivation, which the proposed project intends to do with a novel app system, including a smartwatch app with a specially designed interface to display key data needed to facilitate comprehensive collaboration for moderate- to vigorous-intensity physical activity and supportive interactions between parents and children. The present proposal is to refine and test the feasibility of an app system facilitate collaborative moderate- to vigorous-intensity physical activity with parents and children (9-12 years old), weight gain prevention, and improvements in family communication, support and cohesion.